DNA Adduct Detection and Repair in Mammalian Cells

PROJECT SUMMARY/ABSTRACT
Numerous endogenous agents, environmental carcinogens, and anti-cancer drugs produce bulky base adducts
in the genome. It is expected that the location of these adducts is non-random and that their locations dictate
their pathogenic or therapeutic effects as well as their susceptibility to DNA repair enzymes that modulate these
effects. The long-term goal of our research program is to better understand DNA damage and repair at the
genomic level to aid in predicting and potentially preventing DNA adduct-induced carcinogenesis as well as to
design efficient chemotherapeutic regimens with minimal side effects. The objective of this particular proposal is
to use our novel adductomic-mapping methods (Damage-seq and XR-seq) to locate the exact positions of DNA
lesions in the mammalian genome and the exact positions of DNA incisions performed by the nucleotide excision
repair enzyme system that removes the DNA damage. The rationale for the proposed research is that mapping
damage and repair may reveal unexpected links between environmental carcinogens, mutagenesis, disease and
ageing. We will accomplish this goal by carrying out the following three specific aims: 1) Genomic Single-
nucleotide Resolution Analysis of DNA Damage by Endogenous Agents; 2) Genome-wide Single Nucleotide
Resolution Maps of DNA Damage and Repair by Exogenous Carcinogens; 3) Genome-wide Damage and Repair
Maps of Anticancer Drugs. For this proposal, we will focus on identifying the precise locations and removal of
DNA base damage formed endogenously (glycosylation, oxidative damage) and damage caused by
environmental carcinogens (aflatoxin, diethylnitrosamine) and anticancer drugs (cisplatin, melphalan). Methods
that we developed and further optimized for mapping damage formation and repair will be used throughout this
work. This proposal is innovative because of these unique sequencing technologies that provide high-resolution
DNA sequence information on the formation and repair of damage throughout the entire genome and provide an
unparalleled approach for characterizing endogenous DNA damage as well as damage induced by
environmental carcinogens and anti-cancer drugs. The proposed research is significant because it will address
the question of the role of DNA damage by endogenous agents (glycosylation) of various tissues and its overall
contribution to aging by these methods developed in our laboratory which have unprecedented sensitivity for
genome-wide mapping at single nucleotide resolution in different organs. In addition, the proposed research will
expand our understanding of DNA damage formation and repair in the human genome at an unprecedented
level of detail regarding genomic damage formed endogenously and by environmental carcinogens and
anticancer drugs. Ultimately, this knowledge has the potential to improve the prevention strategies for
environmental carcinogenesis and to lead to the development of new tools for diagnosing and treating cancer.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will identify the exact genomic locations of DNA lesions that occur endogenously during aging as well as those induced by common environmental carcinogens and anti-cancer compounds, and then characterize the factors that influence damage removal at these same sites. The data obtained through this work will provide genome-wide single-nucleotide resolution DNA damage- and repair-platforms that will be widely used by researchers in the fields of DNA damage, repair, and mutagenesis as such contributes to the efforts of a holistic approach to carcinogenesis and chemotherapy. Thus, this project is relevant to NIH’s mission to understand how DNA adducts contribute to human carcinogenesis and affect cancer treatments.